Core A: Administrative

PROJECT SUMMARY
The role of the Administration, Advocacy, Planning and Communication Core (Administrative Core - Core A) is
to coordinate and integrate the multiple components of the Dana-Farber/Harvard Cancer Center (DF/HCC)
Breast Cancer SPORE and to provide scientific, administrative and fiscal oversight of the SPORE Projects,
Cores, the Developmental Research Program (DRP) and the Career Enhancement Program (CEP).
Administrative Management: Core A will facilitate the coordination of the Breast SPORE within the DF/HCC to
meet our scientific aims. Core A will provide the infrastructure for fiscal and administrative oversight for the Breast
Cancer SPORE, including financial accounting and reporting, coordination of research agreements and pre-and
post-award monitoring and reporting in close collaboration with the grants management office at Dana-Farber
Cancer Institute.
Clinical Research Management: Core A will support all investigators in the Breast SPORE conducting clinical
trials and facilitate the interaction and collaborations in the preparation, review and activation of clinical studies
within the DF/HCC Breast Program and external sites.
Integration of SPORE within DF/HCC: Core A will promote coordination and communication between SPORE
investigators, the DF/HCC and its leadership, the DF/HCC Breast Program and its established committees that
support clinical trial development, review, activation and management, as well as access and use of
biospecimens and associated clinical data. Core A will coordinate the Shared Resources Leadership Committee
comprised of the core directors, project leaders, patient advocates and DF/HCC investigators, as well as monthly
Research-in-Progress meetings for frequent updates on progress in the Breast SPORE.
Patient Advocacy: The Core will integrate the work of our large and highly interactive Patient Advocacy
Committee into the planning and evaluation of the Breast SPORE, with guidance from Elizabeth Frank, EdM, as
co-investigator of Core A. The Core will seek to fully engage the patient advocates in the four SPORE Projects,
the DRP, the CEP and the Cores to ensure that the patient perspective is taken into account in the
clinical/translational research.
Planning and Evaluation: Core A will provide rigorous scientific leadership and oversight for the SPORE
Projects, the Cores, the DRP and the CEP. Core A will organize meetings of the Breast SPORE External
Advisory Board (EAB) and Internal Advisory Board (IAB) for evaluation on findings and progress across the
Breast SPORE.

Public health relevance
PROJECT NARRATIVE The Administrative Core (Core A) will coordinate and manage the research projects, core resources, developmental funds and educational activities of the Breast Cancer SPORE. This coordination and management will support SPORE investigators in achieving the translational aims outlined in the projects and cores, with focus on improving outcomes of patients with breast cancer and those at risk of the disease.